Hierarchically-Structured Conduits with Programmed Release of Neurotrophic Factors for Repairing Large Defects in Thick Nerves

PROJECT SUMMARY/ABSTRACT
This project aims to develop, validate, and translate a novel class of nerve guidance conduits (NGCs) for the
surgical repair and healing of large defects in thick peripheral nerves by restoring their continuity and functions.
The research team includes an innovative and productive expert in nanotechnology from the Department of
Biomedical Engineering at the Georgia Institute of Technology and a top neurosurgeon and scientist from the
Department of Neurosurgery at Emory University School of Medicine. Guided by the anatomic structure of
peripheral nerve, as well as the biochemistry and cell biology involved in injury and repair, the investigators
design, fabricate, and validate multi-tubular conduits (mNGCs) using fibers electrospun from a biocompatible
and biodegradable polymer. The mNGC is typically constructed by wrapping a honeycomb array of 3 or 7
small, single-tubular conduits inside a large, single-tubular conduit. The wall of each conduit contains three
layers: uniaxially-aligned fibers to longitudinally guide axonal extension for both the inner and outer layers,
together with random fibers (welded at cross points) sandwiched in between to circumvent tearing or collapsing
during surgery. Besides the topographic cue associated with the aligned fibers, the surface of each fiber in the
inner layer is further engraved with longitudinal nanogrooves to accelerate neurite outgrowth by providing more
sensing targets and contact pads to the filopodia in the growth cone. In addition, neurotrophic factors (NTFs)
are loaded in hollow microparticles of natural fatty acids and then photo-cross-linked to create a unidirectional
gradient in degradation half-life along the conduit. The proposed activities are broadly divided into three major
thrusts: i) controlling the degradation rate of hollow microparticles made of natural fatty acids and thus release
kinetics of NTFs through photo-cross-linking; ii) evaluating the 3-in-1 mNGCs for sciatic nerve repair in a rat
model; and iii) assessing the 7-in-1 mNGCs for facial nerve repair in a porcine model. The NGCs are
anticipated to augment nerve regeneration as a result of the synergistic effect arising from the aligned fibers,
the nanogrooves on the surface of the fibers, and the steady supply of NTFs, improving the health and quality
of life for individuals afflicted by peripheral nerve injuries.

Public health relevance
PROJECT NARRATIVE Peripheral nerve injury is a large-scale problem that affects more than one million people per year in the United States. The investigators propose to design, fabricate, and validate a new class of nerve guidance conduits for the surgical repair of large defects in thick nerves by restoring their continuity and functions. The conduits can enhance nerve regeneration through a synergistic effect arising from uniaxially-aligned fibers, nanoscale grooves engraved on the fibers, and programmed supply of neurotrophic factors at a steady concentration.